Glycosylation Analysis by Sheath-Flow SERS

Project Abstract
Protein glycosylation plays important roles in various human diseases, including cancer, inflammatory, and
neurodegenerative diseases. Glycoproteins, therefore, are important targets for disease diagnosis, prognosis,
and therapeutics. Correct glycosylation of therapeutic proteins is required for optimal efficacy and safety.
However, analysis of glycosylation is challenging due to the enormous complexity of glycan variability.
The current state of art technique is mass spectrometry (MS), which has been a powerful approach for
glycosylation analysis; however, there are classes of glycans that present challenges for MS analysis, such as
the numerous component monosaccharides with the same mass.
This project seeks to develop surface enhanced Raman scattering (SERS) as online detection method for
glycosylation analysis at the levels of small glycopeptides and released glycans. This proposal leverages
recent advances incorporating a novel SERS detector online with chemical separations for highly sensitive and
selective characterization. Published results have successfully shown online separation, identification and
quantification of phosphorylated monosaccharides, demonstrating the tremendous potential of SERS for
qualitative and quantitative analysis of carbohydrates that serve as glycans and glycopeptides.
The specific aims of this project are as follows:
 Aim 1. Demonstrate the utility of the sheath-flow SERS detector for structural analysis of glycopeptides.
We will use a set of structurally similar glycopeptide analogues to demonstrate the capability of the
SERS flow detector for identification and quantification of glycopeptides.
 Aim 2. Qualitative and quantitative analysis of glycans and peptides released from glycoproteins using
LC- SERS. This aim will provide evidence for the capability of our SERS technology to identify and
quantify glycans and glycopeptides with similar chemical structure (e.g. isomers) in complex mixtures,
demonstrating its potential, as a complementary technique to MS, for comprehensive glycosylation
analysis of the levels of glycopeptides and released glycans.
The development of new technologies that provide unique chemical specific information will provide an
alternative tool for increased coverage of the glycoproteome, facilitating the progress in glycobiology.

Public health relevance
Relevance to Public Health. Glycoproteins are important targets for disease diagnosis and therapeutics, where glycosylation alters the function of proteins and correct glycosylation plays a pivotal role in their safety and efficacy as drugs. The goal of this project is to develop new technology for the characterization of protein glycosylation at the level of glycopeptides and released glycans, which remain challenges for current technologies. The technology developed here will provide an alternative tool for increased characterization of the glycoproteome.